Improving colorectal cancer screening decisions through consideration of life expectancy

Project Summary
Colorectal cancer (CRC) is a leading cause of cancer-related deaths in the US, and screening is the most
effective way to reduce colon cancer-specific mortality. For average risk adults, the United States Preventive
Services Task Force (USPSTF) recommends routine CRC screening from 45 to 75 years. Between age 76 and
85, both the USPSTF and the American Cancer Society recommend physicians select appropriate patients for
screening, considering life expectancy, comorbidities, patient preference, and screening history; however,
there are no recommendations to guide clinicians on how to do this. Since the benefits of CRC screening
accrue over a 10- to 15-year period due to the interval required for the progression of adenomas to CRC,
screening patients with a life expectancy of <10 years offers little benefit. Older adults have a substantially
higher risk of adverse events associated with colonoscopy and a low likelihood of actionable findings, making
the balance of potential benefits versus harms unfavorable in patients with a life expectancy <10 years.
Conversely, many patients over 75 years in good health can expect to live 10 years or longer, making
colonoscopy potentially beneficial. Yet under current age-based guidelines, they are unlikely to be offered it by
their physician. Most physicians believe that life expectancy is a sufficient criterion for colorectal cancer
screening discontinuation, but making such predictions is difficult. As a result, many patients with life
expectancy <10 years are being unnecessarily exposed to the harms of screening, while others with a life
expectancy of ≥10 years are missing out on the benefits. To address this, we propose a two-phased
investigation. Multiple life expectancy prediction models exist, but these have not been compared against each
other to determine which is most appropriate for use in cancer screening decisions. In Aim 1 we will develop a
life expectancy prediction model using data from our electronic health record, comparing our results against
two existing models to determine which is most appropriate for routine use. Life expectancy predictions aren't
useful unless physicians feel comfortable using them to guide decision making. To maximize acceptability, we
will develop and test the life expectancy prediction model with input from primary care physicians throughout
the process via interviews and meetings with physician leaders. Through these interactions, we will determine
physicians' preferred presentation style for life expectancy information in the electronic health record. Our
study team has extensive experience creating, implementing, and studying clinical decision support. In Aim 2
we will conduct a cluster randomized trial of a clinical decision support-delivered life expectancy notification on
physician colonoscopy ordering for patients aged >75 years. We hypothesize this intervention will reduce both
under- and over-screening of older patients based on their predicted life expectancy. Together, this series of
investigations will generate essential information to optimize colorectal cancer screening for older adults,
ensuring benefits are maximized and harms are minimized.

Public health relevance
Project Narrative Routine colorectal cancer screening is not recommended for individuals over 75 years of age; physicians are instead encouraged to individualize screening decisions based on patient life expectancy. Yet physicians lack tools to estimate life expectancy, resulting in both over-screening of patients with limited life expectancy and under-screening of patients with ten or more years to live. We propose a cluster randomized trial of a clinical decision support-delivered life expectancy notification to optimize colorectal screening for older patients.